Core E: Outreach, Recruitment and Engagement Core

OUTREACH, RECRUITMENT AND ENGAGEMENT CORE: CORE E - PROJECT SUMMARY/ABSTRACT
The Outreach, Recruitment and Engagement (ORE) Core serves a central role in the JHADRC by (1)
facilitating recruitment of diverse subjects into the clinical research associated with the ADRC, (2) providing a
rich outreach and educational environment that fosters retention of subjects over time and maximizes
agreement to biomarker procedures and brain donation, and (3) conducting a range of educational programs in
the community at large that increases understanding about AD and related disorders, as well as the
importance of research. The success of the ORE Core requires integration of its activities with many of the
other Cores. Working closely with the Clinical Core, we will continue to recruit a diverse subject population into
the JHADRC and facilitate the involvement of these subjects in clinical research projects associated with the
JHADRC. We will expand on our current recruitment efforts in several ways, including by developing video
vignettes of study participants talking about the importance of research for finding improved treatments for
ADRD. Working closely with the Biomarker Core and the Neuropath Core, we will develop brochures and video
vignettes concerning the importance of biomarker procedures and brain donation. We will continue our existing
subject retention efforts, which includes annual activities aimed at all Clinical Core participants, as well as
some activities designed to specifically retain minority participants at a high level. We will continue our
educational programs in the community. These efforts will be expanded by seeking additional partners in the
minority community and by expanding our support of an educational program aimed at elementary and middle
school minority students in the public schools.